Central tolerance mechanisms in B-cell malignancies

ABSTRACT
Humans produce each day ~100 million autoreactive B-cells that express potentially harmful autoantibodies.
This burden of autoreactive B-cells requires a powerful purging mechanism, termed central tolerance, to prevent
autoimmune disease. During the previous period of this R01, we discovered that central tolerance mechanisms
not only remove newly formed autoreactive B-cells but also eliminate B-cell tumors that originate from early
stages of B-cell development, namely B-cell acute lymphoblastic leukemia (ALL), mantle cell lymphoma (MCL)
and chronic lymphocytic leukemia (CLL). Hence, central tolerance could represent a previously unrecognized
vulnerability in B-cell tumors that is orthogonal to conventional mechanisms of drug-resistance.
B-ALL represents the most frequent type of cancer in children. MCL and CLL are common in adults and remain
incurable diseases. Small molecule inhibitors of kinases downstream of the B-cell receptor (BCR) have
substantially extended survival, although treatment with kinase-inhibitors alone invariably selects for drug-
resistance and relapse. Approximately 1.4 million people in the US are currently living with or recovering from B-
cell malignancies (SEER), highlighting the importance of efforts to reduce toxicity and minimize late effects.
Central tolerance mechanisms sense and eliminate transformed B-cells based on pathological signaling: Normal
antigen encounter results in a short transient pulse of PI3K-activation, slow Ca2+-oscillations, tonic NF-B
activation and positive selection. We discovered two distinctive features of pathological signaling that
initiate central tolerance mechanisms:
 Persistent PI3K-signaling (Aim 1) forces aberrant increases of cell size, causing ATP-depletion (AMPK-
phosphorylation) and energy crisis.
 High-frequency Ca2+-oscillations (Aim 2) in pathological B-cells are decoded by NFAT instead of NF-
B, induce NFAT-dependent anergy and cell death.
Here we test the overarching hypothesis that central tolerance mechanisms represent a novel class of
therapeutic targets in B-cell tumors that arise from early B-cell development (B-ALL, CLL and MCL).
Given their B-cell intrinsic activity, targeting of central tolerance mechanisms is expected to have minimal side-
effects.

Public health relevance
NARRATIVE During the previous funding period of this R01, we discovered that -contrary to established dogma- central tolerance mechanisms are not only efficient at removing newly formed autoreactive B-cells but also eliminate B- cell tumors that originate from early stages of B-cell development, including B-cell acute lymphoblastic leukemia (ALL), mantle cell lymphoma (MCL) and chronic lymphocytic leukemia (CLL). Here we test the overarching hypothesis that central tolerance mechanisms represent a novel class of therapeutic targets in B-cell tumors that arise from early B-cell development (B-ALL, CLL and MCL).